Investigating Mechanisms of Neurodegeneration

PROJECT SUMMARY
Disease and injury cause a catastrophic loss of cognitive and motor abilities in the nervous system. Preventing
neurodegeneration is critical to maintaining neuronal function. To develop effective treatments, we first need a
greater understanding of the genetic and cellular mechanisms that determine whether the nervous system
degenerates in response to various insults. Caenorhabditis elegans is a highly tractable model to dissect
conserved molecular and cellular mechanisms. The goal of this proposal is to take advantage of the C. elegans
model to identify regulatory mechanisms of axon degeneration. To reach this goal, I will apply my developing
skills in detailed genetic analyses, laser axotomy, imaging, sequencing, and bioinformatics. The impact of this
project is significant. In addition to providing a critical advance in understanding the fundamental mechanisms
of neurodegeneration, it will also inform future therapeutic approaches that can be manipulated to protect the
nervous system from degenerating.

Public health relevance
PROJECT NARRATIVE Few treatments are available to treat neurodegenerative disease. Investigating the neuronal mechanisms that regulate neurodegeneration will address this critical need. In particular, identifying molecular pathways that protect the nervous system from degenerating will increase both our fundamental understanding of how degeneration is regulated and reveal future therapeutic targets to protect damaged and diseased axons.